Principle Research Core /DRP 1 -DRP 2

B.3.2 Principal Research Core. DRPs are designed as pilot RCTs aimed at developing procedures and data to support larger R-01 submissions for full clinical trials. DRP #1 (Yrs 3-5): TABI for the treatment of depression in adults. This project will build on an existing Internet Intervention, DRP #2 (Yrs 3-5): Ben Van Voorhees, MD. TABI for the prevention of depression in youth. This project will build on the internet Intervention, CATCH-IT (48,49) Each of the technologies developed in the IMPs will be incorporated and piloted In an RCT with youth, ages 13-18, who are at risk for depression.